Novel rifamycins to improve cure rates and shorten treatment of M. abscessus lung disease

ABSTRACT
Mycobacterium abscessus (Mab) accounts for most pulmonary infections caused by fast-growing non-
tuberculous mycobacteria (NTM). Incidence and prevalence rates are increasing throughout the world. There is
currently no reliable cure for Mab pulmonary disease (Mab-PD) despite year-long multidrug treatments that
include underperforming, parenteral and poorly tolerated antibiotics. Among the factors driving the refractory
nature of Mab-PD is intrinsic resistance of the pathogen to many drug classes including rifamycins. The major
goal of this proposal is to optimize rifamycins specifically for the treatment of Mab lung disease.
Rifamycins are oral antibiotics and pillars of TB therapy owing to their exquisite potency against the obligate
pathogen M. tuberculosis (Mtb), favorable pharmacokinetics and excellent penetration to the sites of disease,
but they do not achieve acceptable efficacy against Mab-PD due to intrinsic bacterial resistance not associated
with polymorphisms or mutations in their RNA polymerase target. Rather, we have shown that M. abscessus
inactivates rifamycin via ADP-ribosylation. During the previous funding cycle, we have designed and
characterized rifabutin analogs that block enzymatic ribosylation while maintaining binding to the target, are as
potent against Mab as rifabutin against Mtb, have similarly attractive pharmacokinetic attributes, and most
importantly are devoid of CYP3A4 induction, a major liability of clinical rifamycins.
We propose to complete the pharmacological, safety and efficacy profiling of the current frontrunners to declare
a preclinical development candidate (PDC), then carry out non-GLP IND-enabling studies while establishing an
agreement with a commercial partner and securing additional funding to complete the IND filing package (aim
1). Concomitantly, a backup medicinal chemistry program will leverage the tools and assays developed by our
group, the Cores and Projects, to further improve potency, metabolism, site-of-disease pharmacokinetics and
selectivity index, each contributing to heightened efficacy at tolerated doses (aim 2). To shorten treatment
duration in Mab-PD patients who often present with compromised immune defenses, we will build novel regimens
around a bactericidal backbone that can rapidly reduce bacterial burden. This backbone combines oral β-lactams
and fluoroquinolones with our novel rifamycins, three safe antibiotic classes with a proven records against
mycobacterial lung diseases. Through in vitro and in vivo combination studies, we will prioritize regimens with
the greatest potential for sterilization according to their collective ability to reach and clear bacterial populations
at the site of disease. Our team combines expertise in the medicinal chemistry of rifamycins, anti-mycobacterial
drug discovery, microbiology, infectious disease pharmacology, and drug development, augmented by strong
interactions with the three scientific cores to achieve the proposed goals. We expect to deliver a first-in-class
rifamycin PDC, a non-GLP IND-enabling data package, improved back-up PDCs, and prioritized all-oral
rifamycin-based regimens that can improve cure rates and shorten treatment duration.